Regulatory Consulting to Support Advancement of a Divalent siRNA for Prion Disease

PROJECT SUMMARY
The overarching goal of the parent grant is to file an Investigational New Drug (IND) application
with FDA to enable a first in human trial of our PrP-lowering divalent siRNA therapeutic in prion
disease. The goal of this administrative supplement is to provide funding for regulatory
consultants who can ensure that our IND application is complete, compliant, coherent, and
concise. With guidance from individuals with deep knowledge of the FDA review process, we
can submit an IND application with the best possible chance of success, hopefully allowing us to
bring this promising therapeutic to clinical trials for patients with prion disease.

Public health relevance
PROJECT NARRATIVE Prion disease is a rapid neurodegenerative disease with a single therapeutic currently in clinical trials. We have developed an oligonucleotide therapeutic for prion disease that efficiently reduces the expression of the causative protein, PrP, in animals. Successful completion of this research project would result in submission of an Investigational New Drug (IND) application to the FDA.